Developing an "Out of the Box" Quality Improvement Library for Lung Diseases

Project Abstract
Phrase Health is a clinical decision support (CDS) analytics company that empowers health systems to
efficiently incorporate scientific knowledge into high value clinical care through iterative, data-driven
improvements. CDS is a process for enhancing health‐related decisions and actions with pertinent, organized
clinical knowledge and patient information. While CDS has improved outcomes in sickle cell disease,
myocardial infarction, and many other diseases, its impact has been inconsistent. Continuous evaluation of
CDS is critical to achieve consistent improvement in outcomes, but evaluating CDS is burdensome for health
systems and often not performed. To address these challenges, Phrase Health developed a product called
Outcomes that offers a self-service guided walkthrough for quality improvement (QI) advocates of variable
experience levels to (1) rigorously evaluate the impact of CDS on clinical outcomes and (2) convert data-driven
insights into action. The approach has early market traction with advanced technical users. However, user
feedback cites a need for “out of the box” QI templates (defined as abstracted definitions for CDS
interventions, cohorts, measures, and their associations) to provide more structure and guidance. To address
this market demand, we will generate a library of “out of the box” QI templates accessible to Outcomes
customers for select lung diseases.
In Aim 1, we will translate two QI project templates already established by partner systems within our platform:
(1) emergency management of asthma and (2) emergency management of bronchiolitis. These QI project
templates will be iteratively improved based on user feedback and then assessed for different measures of
value.
In Aim 2, we will use our authoring platform to develop two de novo projects: (1) emergency management
chronic obstructive pulmonary disease (COPD) and (2) ambulatory chronic management of asthma in patients
≥12 years old. Like Aim 1, these will be iteratively improved based on user feedback and then assessed for
value. We will additionally calculate the time and costs associated with developing a de novo QI project
template using our authoring platform.
At the end of this project, we will have demonstrated a library of “out of the box” QI templates focused on a
varied set of lung diseases, but also assessed the necessary investments required to scale to a larger QI
library. These data will begin to address the market’s demand for an “out of the box” library of QI templates and
quantify future investment needs, allowing us to commercialize and accelerate the translation of knowledge
into better health outcomes and support improved health system profitability in a value-based reimbursement
environment.

Public health relevance
Project Narrative Clinical decision support (CDS) has the potential to improve patient outcomes by facilitating adherence to evidence-based practices, but it is burdensome to monitor and is oftentimes ineffective as a result. Phrase Health created Outcomes, a process evaluation web-based product to diagnose when and why CDS is not leading to the intended improvements. We are developing an “out of the box” library of quality improvement (QI) project templates for the Outcomes product that are based on asthma, bronchiolitis, and chronic obstructive pulmonary disease (COPD) best practice guidelines.